Postpartum Recovery from Opioid Use Disorder through Daily Acceptance and Commitment Therapy (PROUD2ACT)

PROJECT SUMMARY/ABSTRACT
The postpartum period for up to one year after childbirth is a vulnerable time for individuals recovering from
opioid use disorder (OUD). Postpartum people with OUD commonly experience psychosocial stressors, such
as mental health problems and child welfare involvement, that can destabilize recovery, increasing risk for
medication treatment for OUD cessation, return to substance use, and overdose. Despite pregnancy-
associated overdose death rates peaking at 7-12 months after delivery, interventions designed to help
people with OUD to maintain stability and continuity in addiction treatment and recovery after transitioning to
the postpartum period are lacking. Mobile health (mHealth) interventions are ideally suited for this purpose
given that they can provide personalized, real-time support in natural environments. The goal of the
proposed research is to develop a mHealth intervention that provides psychosocial and self-management
support to postpartum individuals recovering from OUD. Grounded in the principles of Acceptance and
Commitment Therapy (ACT), the intervention will be iteratively developed and refined with input from
members of the target population and incorporate a just-in-time adaptive intervention (JITAI) component that
delivers real-time notifications to increase user engagement with its content. The following aims are
proposed: (1) develop a mobile ACT intervention specific to postpartum individuals recovering from OUD
using a stakeholder-engaged approach and (2) evaluate the feasibility and acceptability of conducting a
micro-randomized trial (MRT) with postpartum individuals recovering from OUD. This research is part of a
larger comprehensive training plan that will enable Dr. Charron to become an independent investigator
focused on the development and evaluation of novel mHealth interventions that provide real-time addiction
treatment and recovery support to pregnant and postpartum individuals with substance use disorder (SUD).
Proposed training activities are in four areas: (1) JITAI and MRT design, (2) adapting and optimizing behavioral
interventions, (3) behavioral treatments for SUD, and (4) professional development. Expertise of a strong
mentoring team, combined with the rich training environment of University of Oklahoma Health Sciences, will
ensure the success of this project. Completion of the proposed K01 award will provide preliminary data and
a training foundation to support a future R01 proposal to conduct a MRT to optimize the JITAI component of
the mHealth intervention.

Public health relevance
NARRATIVE The postpartum period is characterized physiological and psychosocial changes that can destabilize recovery from opioid use disorder (OUD), leading to medication treatment for OUD (MOUD) discontinuation, return to substance use, and overdose. This project will develop a mobile health (mHealth) intervention based on the principles of Acceptance and Commitment Therapy to support individuals with OUD to maintain stability and continuity in MOUD care and recovery during the postpartum period. Results will establish a novel, safe, and highly scalable resource to prevent postpartum return to substance use and overdose and lay the groundwork for a future micro-randomized trial to optimize the delivery of prompts recommending that users engage with the intervention.